Improved optimization of covalent ligands using a novel implementation of quantum mechanics suitable for large ligand/protein systems.

Project Summary
The value of computational chemistry to commercial drug discovery is now well-established. Virtual screening
(including molecular docking) now jumpstarts most discovery efforts. Tools such as molecular dynamics and
free energy perturbation are increasingly used to inform the later stages of lead refinement. The growing
importance of computational structure-based methods has influenced the types of ligands that are identified.
The energy of a molecular system is fully described by quantum mechanics (QM). However, QM equations are
extraordinarily complex, and applying QM to realistic models of relevance to drug discovery on a suitable
timescale has traditionally been impossible. Instead, a simplified formulation of molecular interaction, molecular
mechanics (MM), has been used. The analytic equations of MM can be easily assessed directly from the
coordinates of a molecular structure. However, MM suffers severe limitations relative to the QM representation,
including poor estimation of certain types of molecular effects (polarization, π-stacking, and interactions with
metals and halogens) and an inability to deal with changes in topology, including bond creation/breakage.
Because of this latter limitation, drug discovery in the computational era has focused largely on non-covalent
inhibitors. However, covalent drugs are historically significant (aspirin, penicillin, more than 50 FDA approved
drugs in total). A growing realization that covalent drugs can provide a way to address problems that non-
covalent ligands cannot address has led to a resurgence in interest in drug covalency. Among the targets that
are especially well suited for covalent drugs are: drugs that differentiate among similar binding sites (e.g., the
Kinase family); Protec drugs that can lead to protein degradation; and ligands that can target “undruggable”
targets such as protein-protein interactions. In turn, this realization has led to renewed interest in QM methods.
We recently described a new, novel implementation of QM that (for the first time) allows accurate DFT/QM to
be applied to large ligand/protein systems with sufficient throughput for drug discovery. This new approach
allows calculations to be carried out in less than an hour on a massively distributed computing platform, as
compared to weeks or months using traditional QM implementations. This makes it possible to use QM-based
computational tools to optimize covalent ligands--including such previously elusive goals as tuning the
“warhead” reactive group on the ligand. Subsequent work we have carried out has further demonstrated the
ability of QM to improve upon standard scoring approaches for covalently-bound ligands. This has led us to
develop an approach that will streamline and optimize the process of computationally-driven covalent ligand
characterization. The result will be a QM approach that can reliably focus ligand optimization—including the
warhead—on a timescale commensurate with modern drug discovery.

Public health relevance
Project Narrative Computational chemistry has had a hugely beneficial impact on the discovery of drugs that bind non-covalently (without forming a bond with the target protein)--both in terms of the mean number of years between the initiation of a discovery project and the move to clinical trials, and on the associated cost. In contrast, although drugs that bind covalently (by forming a bond with the target protein) have been exceptionally important (e.g., Aspirin, Penicillin), and although certain important drug targets can only be addressed via covalently binding drugs, computational chemistry has had little impact on this class of drugs, since probing covalent bonds requires a quantum mechanical (QM) approach that has not traditionally been suitable for drug discovery. Based on promising preliminary results using QM to rescore and characterize covalently bound ligands, we propose a new approach to covalent scoring that automates the process while providing turnaround time suitable for integration in a modern pharmaceutical drug optimization workflow.